ARC Administrative Core

Abstract Admin Core

The Administrative Core will provide leadership in research, research methodology development, and
information dissemination on topics relevant to our overall TSRI-­ Alcohol Research Center (ARC) goal. The
focus of our renewal is that dysregulation in the brain stress system mediates the transition from acute
withdrawal to protracted abstinence to promote vulnerability to relapse, and our ARC is designed to translate
the discoveries of preclinical TSRI-­ARC investigators for potential therapeutic use using proof-­of-­concept
human laboratory testing. It coordinates all TSRI-­ARC activities, and will help support and coordinate the TSRI-­
ARC with the Center at Large. Functions of the Administrative Core will be to provide scientific and
administrative leadership for the by monitoring and enhancing collaborative interactions among the support
Core and Research Components, to facilitate the dissemination of expertise between support Core and
Research Components by organizing regular TSRI-­ARC meetings, seminars, conferences and workshops to
stimulate exchange of scientific information among the Center faculty and staff, to promote the sharing of
multidisciplinary resources and services among the support Core components and investigators, and to
disseminate new research knowledge to academic, treatment and lay communities by engaging in community
outreach activities designed to improve awareness, prevention and treatment of alcoholism and alcoholic
diseases, and supporting regional and national research initiatives aimed at improving prevention and
treatment of alcohol use disorders and addiction. It will arrange regular meetings of the Steering Committee
and Program Advisory Committee and monthly meetings of the Participating Investigators. The Administrative
Core is organized to ensure proper functioning of the Center to benefit investigators, their utilization of Center
resources to enhance and expand alcohol research throughout the TSRI-­ARC and Center at Large, and to
provide review and advisory functions.